HEP DART 2021: FRONTIERS IN DRUG DEVELOPMENT FOR HEPATOLOGY

Abstract/ Project summary: HEP DART 2021: Frontiers in Drug Development for Hepatology
HEP DART: Frontiers in Drug Development for Hepatology is an independent biennial conference attracting at
least 250 attendees per meeting for the past 24 years. HEP DART is open to anyone interested in therapies for
viral hepatitis and chronic liver disease. The content of this conference was developed to interest primarily
scientists and clinical researchers with a focus on drug development and vaccinology. The aim of HEP DART
2021 is to assemble clinicians, researchers, basic scientists, nurses, physician assistants and advocates
together to advance our knowledge of the ongoing drug development processes in the treatment of viral hepatitis
(HBV, HCV, HDV, HAV and HEV), non-alcoholic steatohepatitis (NASH) and hepatocellular carcinoma (HCC).
HEP DART will uniquely blend the areas of biology, chemistry, pharmacology and clinical research to provide
the scientific community with an increased understanding of the current and future challenges in therapeutics for
liver infection, disease and cancer. OBJECTIVES: (1) Highlight advances in drug development against viral
hepatitis such as HBV, HCV, and HDV. (2) Evaluate the progress toward the elimination of HBV and HCV as
public health threats in the context of the COVID-19 pandemic. (3) Describe the latest developments in HBV
curative strategies, including combination therapy for cure. (4) Highlight the latest findings in immunity, flares,
immunotherapy and cure strategies. (5) Highlight advances in drug development against NASH, NAFLD, fibrosis
and HCC. (6) Describe novel biomarkers for viral hepatitis, liver disease, and treatment outcomes. (7) Review
the latest findings related to COVID-19 and liver disease. (8) Review current treatment and vaccination
guidelines for viral hepatitis; describe advancements in improved treatment regimens. (9) Examine recent work
and future directions for vaccines to prevent HCV infection. (10) Understand the consequences of HBV infection
and NASH in pediatrics and adolescent populations. (11) Assess the role of therapeutic vaccines in future
therapies for viral hepatitis, NASH, and co-infections with HIV. (12) Understand the epidemiology and
pathogenesis of viral hepatitis including HBV-HDV, HCV, HAV and HEV. (13) Understand treatment in the
context of co-infection with HIV and other viruses. METHODS: HEP DART 2021 comprises four days of in-
person scientific presentations, delivered in both oral and poster presentations formats via non-concurrent
sessions. Main sessions and keynote speakers will also be taped and streamed virtually shortly after the meeting.
Emory University, Office of Continuing Medical Education will designate category 1 credits toward the AMA
Physician’s Recognition Award to this accredited program. HEP DART provides a relaxed and scientifically
stimulating atmosphere for both PhDs and MDs to network and learn together. Support is requested to help
defray costs of scholarships and travel grants for young investigators, women, visible minorities and other under-
represented delegates.

Public health relevance
R13 NIH grant application HEP DART 2021: Frontiers in Drug Development for Hepatology Project narrative: Relevance: Since its first installment in 1995, HEP DART has provided a strong forum for national and international viral hepatitis and liver disease researchers and health care professionals to learn about the latest developments in novel preventative, therapeutic, and curative strategies. This biennial conference encourages young scientist participation through the provision of scholarships to oral abstract presenters and other underrepresented delegates. In line with previous years, HEP DART 2021 will provide accredited Continued Medical Education sessions for physicians and clinicians, ensuring a positive impact on medical practices of the greater viral hepatitis and liver disease community.